Histopathology and Biospecimen Core

Project Summary/Abstract – Histopathology and Biospecimen Core (HBC)
The Histopathology and Biospecimen Core (HBC) represents an integral component of the Fred Hutchinson
Cancer Center (Fred Hutch) Lung SPORE, supporting the translational goals of the Projects as well as future
SPORE-funded development projects. The mission of the HBC is to facilitate discovery and rapid translation of
discoveries into clinical care. To this end, the HBC manages the acquisition, annotation, processing and
distribution of biospecimens from patient-derived and SPORE-funded experimental mouse models. The HBC
partners with NWBioTrust (NWBT), and Fred Hutchinson/University of Washington Cancer Consortium (CCSG)
– a funded collaborative resource for obtaining high-quality, well-annotated and appropriately-consented and de-
identified biospecimens for innovative research. In addition to biobanking activities, the HBC is responsible the
for managing the performance of downstream tissue-based assays, leveraging a suite of cutting-edge
histopathologic and imaging capabilities supported by the Fred Hutch in its extensive network of Shared
Resources. These capabilities include, but are not limited to, routine histopathologic services, pathology review
and consultation, immunohistochemistry (IHC), fluorescent in-situ hybridization (FISH), DNA/RNA extraction,
Nanostring-based transcriptional profiling, multiplex immunohistochemistry (M-IHC) and digital image analysis,
and Co-Detection by Indexing (CODEX) performance and analysis. The HBC will provide SPORE investigators
with biospecimens (e.g. serum), derivatives of biospecimens (e.g. unstained slides, DNA,RNA) as well as quality-
controlled data (e.g. images and image analysis-based data).